Discovery of chemical probes for uveal melanoma

DESCRIPTION (provided by applicant): There is an urgent need to develop novel therapies for patients with highly malignant uveal melanomas in the eye. Patients with uveal melanoma die within 1-2 years of diagnosis despite current conventional therapies, including eye enucleation, brachotherapy and chemotherapy. Hypoxia drives tumor progression by activating angiogenesis, cell motility and metastasis, as well as metabolic adaptation to growth under a hypoxic environment and is a major factor in the resistance of cancer cells to radio- and chemotherapies. Hypoxia activates transcription factors of the Hypoxia-Inducible Factor (HIF) family that induce the expression of genes that encode pro-angiogenic factors and glycolytic enzymes essential for tumor growth and favor tumor invasion. Based on these findings, we formulated the central hypothesis that development of hypoxia and activation of the HIF pathway play a critical role in ocular cancer growth and spread, and that therapeutic targeting of this pathway using small molecule inhibitors will inhibit ocular tumor growth and metastasis. We have generated substantial preliminary data validating this concept. We show that our lead probe (KCN1) is a potent inhibitor of the in vivo growth of uveal melanoma in the eye (70% tumor size reduction) and its metastasis to the liver (50% reduction in number of metastases), while being extremely well tolerated. The overall goals of this proposal are to refine the structur of the novel HIF pathway inhibitor (HPI) chemical probes we developed, optimize their potency and pharmacological properties, leading to the identification of 1- 2 clinical lead probes that wil be ready to undergo IND-directed pharmacology and toxicology towards phase 1 clinical testing in patients with malignant uveal melanoma through the NCI NExT program. Our multi- disciplinary team has expertise in major aspects of chemical probe development and will divide the project tasks into the following aims: screening analogs of the parent compound in primary and secondary assays to identify and confirm chemical probes with improved potency and solubility (Aim 1); screening analogs of the optimized probes for improved pharmacology and formulation development (Aim 2); and determine the anti- tumor efficacy of the optimized lead probe(s) in orthotopic uveal melanoma models in mice (Aim 3).

Public health relevance
PUBLIC HEALTH RELEVANCE: We want to further optimize the pipeline of novel anti-cancer chemical probes we have discovered, by improving their potency, activity, pharmacological properties and establishing their preclinical safety. This will accelerate their translation toward clinical trials to test their potential as novel drugs for the treatment of patients with malignant ocular tumors, and possibly other cancers. ! __SpecificAimsTextDelimiter__ Specific Aims: This application is in response to PAR-12-060: Solicitation of Validated Hits for the Discovery of in vivo Chemical Probes." The objective of this PA is to "create an opportunity for integrated research in biology and chemistry on structure activity relationships (SAR) of novel compounds through an iterative and parallel optimization process, which ultimately allows the researchers to take a holistic approach and make rapid progress toward successful development of in vivo chemical probes." In line with this objective, our goal is to develop chemical probes applicable for in vivo targeting and treatment of malignant tumors, we propose to further develop novel anti-tumor small molecules we identified, augment their efficacy in cell culture and animal models for ocular melanoma, and translate these findings towards clinical trials. Uveal melanomas (UM) are highly malignant cancers for which effective treatments are lacking and have not attracted appropriate resources. About 3,000 new cases are diagnosed and 1,000 deaths reported annually in the United States. The central hypothesis of this application is that the development of hypoxia and the activation of the Hypoxia-Inducible Factor (HIF) pathway contribute to malignant behavior and therapeutic resistance in UM, and that small molecule inhibitors targeting the HIF pathway will inhibit their growth. The rationale underlying our hypothesis is that hypoxia, a reduction in partial oxygen pressure, is a micro-environmental change that occurs in UM and is a major inducer of tumor growth that confers resistance to radio- and chemotherapies. Hypoxia induces the activation of the HIF family of transcription factors and fosters tumor adaptation to anaerobic metabolism, promotes tumor invasiveness, and activates angiogenesis and metastasis through the expression of HIF target genes that control these processes. A significant association between tumor grade, vascularization, and HIF-1α expression has been found in solid tumors, while HIF inhibition decreases experimental tumor growth. Furthermore, HIF-2 expression is associated with cancer stem cells, suggesting that both isoforms need targeting. Therefore, tumor cells over-expressing HIF represent an important target for anti-tumor therapy. These findings support our hypothesis that inhibitors of the HIF pathway will be able to interfere with UM growth and provide therapeutic potential for the unmet medical need of these patients. Presently, there are no clinically applicable specific HIF-1 or HIF-2 pathway inhibitors. Towards our goal of designing small molecule inhibitors of the HIF pathway, we have already generated substantial preliminary data by screening a natural product-like combinatorial library of 10,000 small molecules using a HIF reporter gene cell-based assay. We identified and validated several lead chemical probes that have potent HIF inhibitory activities and showed that they could antagonize primary and metastatic UM growth in an orthotopic mouse model. Our investigation into the mechanism(s) of action has shown that our lead probe targets the CH1 domain of transcriptional co-factors p300/CBP and prevents their interaction with HIF-1α. The current proposal will focus on the most promising class of UM inhibitors identified, optimize these probes for both potency and pharmaceutical properties through an iterative and parallel optimization process, define their target binding affinity and specificity, and determine their effectiveness as in vivo therapeutic agents for the treatment of UM using animal models. To achieve these goals we have built a multi-disciplinary team integrating cancer biologists, oncologists, chemists, structural chemists and pharmacologists. Our team is functional as we already reported our initial findings in 6 collaborative publications, and we made significant progress towards our specific aims: Aim 1- Medicinal chemistry 'Hit' to 'Lead' probe optimization: Screen analogs of the parent compound to identify probes with improved potency and solubility (year 1-2). Aim 2- Lead probe pharmacology optimization and formulation development (years 2-3) Aim 3- Determine the anti-tumor efficacy of the optimized lead probe(s) in orthotopic UM models. (years 2-3) At the completion of the studies in Aims 1-3, our expectation is that we will have identified 1-2 chemical probes that will be candidates toward further clinical development. We will have shown their in vivo safety and therapeutic efficacy in models for highly malignant uveal melanoma (UM), for which no efficacious therapies are currently available. This will position us optimally to have the selected lead probe(s) undergo future development in partnership with the NCI NExT program, including GLP pharmacology and toxicology, so that an IND can be filed for the initiation of a clinical trial. The novel chemical probes presented in this proposal have great potential for cancer therapy as they are based on a novel natural product-like chemotype with properties compatible with systemic delivery and safety profile. These small molecules have broad applicability to treat a variety of cancer types that develop hypoxia or have an activated HIF pathway regardless of their tissue of origin and genetic composition. This study is first to establish the feasibility of this novel approach in UM, a cancer type for which current therapeutic options are very limited. Our studies have the potential to directly benefit human health through the development of a novel type of clinical treatment that will improve the survival of patients with malignant ocular cancer and possibly other neoplasms.